INTERNAT'L SOCIETY FOR EXPERIMENTAL HEMATOLOGY MEETING

This grant application requests funding for support of the 23rd Annual Meeting of the International Society for Experimental Hematology to be held in Minneapolis August 21 - 25, 1994. The grant will primarily support speakers at the meeting through travel awards and will also provide a minor portion of the anticipated operating costs.